MetaOmics

MOSR Summary
The mission of the Sidney Kimmel Cancer Center MetaOmics Shared Resource (MOSR) is to provide a
comprehensive resource across the SKCC consortium that meets all the “omics” needs of SKCC members
through a single portal. These “omics” include: genomics, epigenetics, transcriptomics, proteomics, glycomics,
metabolomics, and lipidomics. The MOSR evolved during the last project period through a carefully planned
expansion of the SKCC’s former Cancer Genomics Shared Resource (CGSR). The CGSR, founded in 2007 by
Paolo Fortina, MD, PhD, fostered leading-edge cancer research through its technology and specialized
expertise in genomics and bioinformatics. In response to growing demand for a broader range of omics
capabilities, the CGSR combined with a developing facility at Drexel University College of Medicine, led by
Garth Ehrlich, PhD, FAAAS. Dr. Ehrlich now serves as the MOSR Director, and Dr. Fortina serves as Co-
Director of the combined facility. New or enhanced services include: consultative faculty-level experimental
design services; state-of-the-art laboratory services covering multiple omics disciplines; and data analysis
services for high throughput and high fidelity omics-based technologies provided by a team of highly trained
bioinformaticians. Besides new instrumentation platforms, the MOSR continues to provide Illumina-based high-
throughput short-read DNA sequencing and RNAseq capabilities, as well as array-based technologies. Current
goals for the MOSR include: 1) Leverage the latest genomics, proteomics, and metabolomics technologies to
serve SKCC members conducting advanced cancer research; 2) Provide expertise and guidance in
experimental and project design and analysis through a single portal; 3) Promote a user friendly environment
by providing expert consultations, high-quality services at reasonable fees, fast turnaround, and ready access
to equipment after training; 4) Provide bioinformatics analysis on all samples ensuring rapid feedback on
sample and library quality, suggest future experiments indicating whether additional analyses are warranted; 5)
Coordinate with other SKCC Shared Resources, particularly Biostatistics, Translational Pathology, and Flow
Cytometry, to efficiently and effectively support larger-scale projects on behalf of all users.